Mechanistic neural circuit models and principles

Summary/Abstract, Project 3
Even in the same environment, an animal may make different decisions on different occasions,
because its internal state, such as engagement in a task, interacts powerfully with external inputs
to determine behavior. This proposal’s overarching goal is to understand how internal states
influence decisions and to identify the underlying neural mechanisms. The team is part of the
International Brain Laboratory (IBL), an established consortium that has developed a
standardized mouse decision-making task and standardized methods for training, neural
measurement, and data analysis, along with a working, scalable infrastructure for sharing
data. The goal of Project 3 is to synthesize the findings of experimental Projects 1, 2, 4, and 5
into circuit-level mechanistic models of the IBL task. The task involves hierarchical, probabilistic
decision-making through sensory evidence integration to make left-right decisions about where
the stimulus is on the current trial, along with integration on a longer timescale to estimate the
slowly varying left-right biases in where the stimuli are more likely to appear. Initial models not
only will be trained to reproduce expert-level task performance, but also will include general
biological constraints on neural dynamics and anatomical connectivity gradients. They will be
analyzed for their learning dynamics, and for which parameters are the handles through which
internal states exert their effects on circuit computation and dynamics. These models will yield
predictions on multiple levels of abstraction: state-space predictions, network structure
predictions, and anatomical predictions. The resulting models will be deployed in a tight loop with
all experimental projects, to guide experimental design; serve as ground-truth testbeds for
perturbative and causal connectivity analysis studies; and link statistical analysis results from data
with mechanistic interpretations. The results of these experiment-model prediction comparisons
will then be used to further refine and elaborate the models. Project 3 researchers will incorporate
the experimentally derived neural activity data, causal connectivity by anatomical region data, and
structural cell-type and connectivity data to further constrain the models. Finally, Project 3 will
also generate highly simplified abstract neural circuit models, using novel methods of model
compression to elucidate the general principles underlying hierarchical decision-making in the
brain. All this work involves the use and de novo development of cutting-edge modeling,
statistical, and data analysis tools. The work of Project 3 will thus deliver a mechanistic circuit-
level understanding of this proposal’s overarching hypothesis that information flow and
communication across brain regions during decision-making depends on internal state.